Nonclinical Strategies for Refining Combination Rectal Formulations

In the face of the existing HIV-1 epidemic, an effective mix of prevention modalities are needed to begin to reduce the incidence of HIV-1. This includes the used of topical microbicides. These are products that would be used to prevent the sexual transmission of HIV-1; including receptive anal intercourse. Project 1, Nonclinical Strategies for Refining Combination Rectal Formulations, of this U19 will strive to ensure that a safe and effective rectal microbicide will be developed. To date, the Phase 2b trials of

Public health relevance
HIV-1 infection is a devistating disease that is mostly spread through sexual activity. Because of the high likelihood that a couple will participate in anal sex without a condom, we need to prevent possible HIV-1 infection through the rectum. To do this, rectal microbicides (products that kill HIV-1) are being developed to use just before or just after anal sex.